Improving prediction of persistent hypoxemic respiratory failure to support clinical trial enrichment

Abstract: Over 30% of patients who develop acute hypoxemic respiratory failure (AHRF) and require ventilator
support will die in the hospital. Treatment for AHRF remains extremely limited, as nearly every clinical trial in
the last 20 years has failed to demonstrate improvements in mortality. A major obstacle for these trials is that
most patients improve with existing care; this dramatically limits our ability to detect benefits for the remaining
patients with persistent HRF, who are the ones most at-risk for death and in-need of new therapies. Currently,
there are no accurate ways to distinguish patients with persistent HRF early, when trial enrollment and
intervention is critical. The goal of this project is to develop robust models to identify patients at high risk for
persistent HRF early, by using innovative opportunities in data science and machine learning to capture
complex data sources (text and imaging) and accurately predict risk. The project will also allow Dr. Neha
Sathe, an early career investigator and Pulmonary & Critical Care physician, to gain expertise in state-of-the-
art methods to develop, evaluate, and improve multisource prediction models in real-world settings. In Aim 1,
Dr. Sathe will develop and validate models that identify patients at high risk for persistent HRF, by integrating
retrospective data from electronic health records, chest radiograph reports, and banked blood at two medical
centers. In Aim 2, she will evaluate and explain these models in a new prospective cohort, to develop
strategies and infrastructure for deploying and monitoring these models in future work. In Aim 3, she will
develop novel methods to analyze sources of data with high potential to improve prediction of persistent HRF
(chest radiograph images and tracheal aspirates, which are readily collected but under-leveraged). This work
will yield models that improve the ability of trials to identify effective therapeutics for high-risk patients, minimize
exposure to potentially costly or toxic therapeutics in patients likely to resolve, and provide significant insights
to advance precision medicine. This work will also yield research infrastructure that can be adapted to
rigorously develop and test predictive models for other clinical problems in critical care. To achieve these aims,
Dr. Sathe will have complementary mentorship across the thriving ecosystem at the University of Washington
for translational AHRF research, medical data science, and informatics. Altogether, this proposal aligns with
NIH strategic objectives to leverage new opportunities in data science, and will support Dr. Sathe's long-term
goal of understanding how to best use these opportunities to individualize and improve the care of patients with
AHRF.

Public health relevance
Project Narrative/Public Health Statement: Many patients with acute hypoxemic respiratory failure will improve with current care, while others persist and have high mortality, morbidity, and resource utilization. This proposal will use machine learning to yield innovative tools that identify patients likely to persist, which is essential for clinical trials to be able to detect effective treatments, and avoid unneeded, costly, and/or toxic investigational treatments in patients likely to improve. In the future, the research infrastructure built for this proposal will be used to develop, evaluate, and improve machine learning for other clinical problems in the intensive care unit.